THE CONTRACTOR SHALL PROVIDE COMPREHENSIVE CLINICAL SITE AND STUDY MONITORING SERVICES FOR THE NCCIH-FUNDED (PRIMARY OR SECONDARY) EXTRAMURAL CLINICAL

CLINICAL STUDIES MONITORING SERVICE (CSMS), NATIONAL CENTER FOR COMPLEMENTARY AND INTEGRATIVE HEALTH. This is a monitoring contract that performs quality assurance on NCCIH-funded extramural clinical trials in integrative health.